Optimizing Low Threshold TelePrEP Care in Syringe Service Programs for People who Inject Drugs in Appalachia

ABSTRACT
Kentucky (KY) is a high priority Ending the HIV Epidemic (EHE) jurisdiction due to heavy rural HIV burden and
exceptionally high rates of new HIV diagnoses driven by injection drug use (IDU). Despite ongoing need for
robust HIV prevention and the strong evidence for Pre-Exposure Prophylaxis (PrEP), uptake remains severely
limited among people who inject drugs (PWID). PWID are notably impacted by structural challenges that
impede entry and retention in PrEP care, including poverty and unstable housing, violence, social isolation,
and stigma; in rural and remote areas, including Appalachia, limited healthcare access and a dearth of PrEP
providers further constrain access to PrEP along geographic boundaries. An interim assessment of EHE
progress notes that PrEP coverage remains well below threshold to reach established EHE targets, and sets
out broad policy recommendations to enhance PrEP access by engaging people where they are. For
PWID in particular, there is broad scientific consensus that PrEP efforts be intensified and intentional in
supporting low threshold PrEP access. The proposed R34 will leverage KY’s robust harm reduction
infrastructure to develop, integrate and test a low threshold peer-facilitated TelePrEP intervention for
Appalachian PWID in syringe service programs (SSPs) that operate within “PrEP deserts,” filling a critical need
to implement innovative approaches that mitigate geographic disparities in PrEP access. The PI’s ongoing
research and existing partnerships with local health department SSPs in Appalachian KY have demonstrated
that PWID have low PrEP awareness and social determinant barriers to PrEP uptake, yet interest in PrEP is
high, at 73%. Building on this existing work, we will conduct a pilot randomized trial to examine efficacy on
PrEP initiation (measured by dispensed PrEP prescription) and retention in PrEP care 3- and 6- months post-
baseline (measured by self-report and biomarker confirmation) as well as implementation outcomes guided by
the Implementation Outcomes Framework. The Specific Aims are to: 1) Collaborate with the Clark County
HD (CCHD) and Kentucky River District HD (KRDHD) harm reduction communities to develop the optimal
content, delivery structure, and implementation strategies for the peer-facilitated TelePrEP intervention in
SSPs and rapidly manualize the novel low threshold protocol; 2) Conduct a pilot randomized trial to evaluate
the preliminary efficacy of: a) peer-facilitated, integrated TelePrEP; compared with b) peer-delivered PrEP
education and referral, on PrEP initiation and persistence among Appalachian PWID; and, 3) Examine
feasibility, acceptability, appropriateness, and fidelity implementation outcomes of the two intervention
comparators among PWID participants and partner harm reduction staff using a mixed methods approach.
The proposed study will establish preliminary evidence and proof-of-concept for an integrated low-threshold
TelePrEP intervention for Appalachian PWID, which is designed to increase PrEP initiation and persistence.

Public health relevance
PROJECT NARRATIVE Kentucky (KY) is a high priority Ending the HIV Epidemic (EHE) jurisdiction due to heavy rural HIV burden and exceptionally high rates of new HIV diagnoses driven by injection drug use. A central pillar of EHE is the prevention of new HIV infections through scale up of PrEP in key populations, including people who inject drugs (PWID), who are notably impacted by structural challenges to PrEP uptake. This R34 application proposes to develop, integrate and test a low threshold peer-facilitated telehealth (TelePrEP) intervention for Appalachian KY PWID in syringe service programs (SSPs), filling a critical need to implement innovative approaches to mitigate geographic disparities in PrEP access and improve the care cascade among PWID.